Human anti-viral immune responses in tissues and circulation

OVERALL: PROGRAM SUMMARY
Human immune responses to viral infection and vaccination engage a complex, multi-scale system involving
numerous diverse cellular populations residing in and circulating between tissues. The Columbia HIPC Center
has established a framework for human immunology studies that includes a unique tissue resource where
lymphoid, mucosal and peripheral tissue are obtained from individual organ donors, vaccine cohorts treated
with immunomodulatory therapies, and technology for single-cell genomics, imaging, and computational
biology. The overall goal of the Center is to obtain in-depth profiles of human innate and adaptive immune cells
in response to viral pathogens (including influenza, CMV, and SARS-CoV-2) and vaccine antigens in both
tissues and circulation, to provide a comprehensive assessment of the human immune response across the
body and over age. In Project 1 (PI: D. Farber), we will quantitatively analyze the contributions of virus type,
tissue, age, and sex on human anti-viral T cell immunity and define the functional states and clonal signatures
of T cells in diverse tissue sites with single-cell resolution. Project 2 (PI: B. Reizis) will produce a
comprehensive characterization of human dendritic cell composition and function in tissues and circulation in
the context of anti-viral immune responses and vaccination. In Project 3 (PI: P. De Jager), we will leverage a
cohort of multiple sclerosis patients treated with molecularly targeted drugs that selectively perturb immune
populations in a compartment-specific fashion. By following this cohort longitudinally through multiple cycles of
vaccination with sophisticated molecular profiling and single-cell analysis, we will answer fundamental
questions about the role of circulating and tissue-resident lymphocytes in maintaining T cell function and
responses to vaccines. All of these projects will be supported by five cores. The Administrative Core will
coordinate inter- and intra-center communication and collaboration, while managing financial aspects of the
Center. The Single Cell Core will provide state-of-the-art protocols and technologies for single-cell genomics,
including CITE-seq, scTCR-seq, scPLATE-seq, and a new technique for linking antigen-specificity with CITE-
seq and scTCR-seq of individual T cells called TetTCR-seqHD. The Immune Assay and Imaging Core will
provide quantitative analysis of antibodies and high-dimensional imaging technologies for spatial analysis of
gene signatures and cell-cell interactions in situ. The Clinical Core will organize tissue and patient cohort
resources, distributing tissue specimens and blood to project investigators. Finally, the Data Management and
Analysis Core (DMAC) will offer innovative computational tools for systems-level and single-cell analysis;
infrastructure for computing, data storage, and data curation; and tools for data sharing to ensure the long-term
impact of the Center’s efforts. Together, the Columbia HIPC will uncover new insights into human immunity
and produce valuable data resources and reference maps for defining human immune responses across the
body and the human population.

Public health relevance
OVERALL: PROJECT NARRATIVE The human immune response to virus infection is remarkably heterogeneous. The COVID-19 pandemic caused by the novel respiratory virus, SARS-CoV-2, revealed major gaps in our understanding of human anti- viral immunity, and the different responses and susceptibilities between individuals based on age, sex, and other factors. This proposed program will advance our understanding of human immune responses to viruses and vaccines by studying tissue sites where immune cells reside and function to obtain a more complete assessment of the factors which control immune protection than can be measured in peripheral blood.